DEVELOPMENT OF A NOVEL PEDIATRIC COMBINATION VACCINE AGAINST HIV & TB INFECTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The objective of this project is to test a recombinant, highly attenuated human Mycobacterium tuberculosis vector expressing SIV/ HIV antigens for immunogenicity and efficacy as a vaccine in newborn rhesus macaques.